Diagnosis and Treatment of APOBEC Mutagenesis in Metastatic Breast Cancer

Diagnosis and Treatment of APOBEC Mutagenesis in Metastatic Breast Cancer
Summary: Although the majority of early stage estrogen receptor (ER)-positive breast cancers are cured
through multimodality care, metastatic ER-positive breast cancer remains a lethal disease. Insights into this
discrepancy have come through comparative genomic analyses of primary and metastatic tumors. We and
others have identified several mutations affecting specific genes that are more prevalent in metastatic cancers
than in their primary counterparts, including ESR1, ERBB2, and NF1. These mutations result in resistance to
front-line endocrine treatments that are the mainstay systemic therapy in ER-positive breast cancer. Even
more striking than such individual mutations, however, has been the finding that certain `mutational signatures'
are enriched in metastatic disease as compared to primary breast cancers. These mutational signatures
represent the DNA damage and repair processes that shape the cancer genome and can give rise to such
mutations and the transformed phenotypes they convey. A glaring and consistent finding from multiple large-
scale sequencing studies has been that the APOBEC mutational signature is both enriched and highly
prevalent in ER-positive metastatic disease, comprising the dominant mutational signature for these drug-
resistant and ultimately lethal cancers. Our preliminary data confirm that APOBEC activation can promote the
development of endocrine resistance in ER-positive cancer models and is associated with characteristic
APOBEC-mutational changes in many drug resistance alleles. Together, these results point to the APOBEC
mutational process as a key driver in the development and pathogenesis of ER-positive metastatic breast
cancer and endocrine therapy resistance. In this highly collaborative and innovative project, we propose three
specific aims to advance the APOBEC mutational process as a biomarker and therapeutic target in breast
cancer. (1) We will develop and utilize robust bioinformatic methods to detect the presence and the timing of
onset of the APOBEC mutational signature from clinical NGS datasets of both tumor and cell free DNA
(cfDNA). We will further ascertain if a promising IHC assay for the A3B enzyme can identify those ER-positive
cancers likely to subsequently develop an APOBEC mutational signature. (2) We will determine the
mechanisms and kinetics of APOBEC's contribution to endocrine resistance. We will use isogenic cell line
models and patient derived xenografts to dissect the types of resistance patterns that are caused by APOBEC
as well their timing and whether the endocrine therapy itself contributes to the induction of APOBEC activity.
(3) We will assess both immunologic and synthetic lethal approaches to targeting tumors in which APOBEC
activity is induced and determine their capabilities in killing APOBEC-positive cancers. We anticipate that our
findings will uniquely position our team to launch clinical trials testing specific approaches to diagnose
APOBEC-positive tumors, to prevent the development of resistance to endocrine therapies, and to target the
largest subset of ER-positive endocrine-resistant metastatic breast cancers.

Public health relevance
Relevance: Metastatic breast cancer is one of the leading causes of death among women in the United States with mortality linked to the disease becoming resistant to hormonal therapies. Analyses of breast cancers that are metastatic reveal the presence of pathogenic DNA mutations originating from the mutagenesis process induced by the activity of the APOBEC family of antiviral enzymes. This project will facilitate clinical identification of cancers in which APOBEC is or will become active, elucidate how APOBEC promotes drug resistance, and develop new methods for treating APOBEC positive tumors.